DIVERSITY OF A1-ADRENERGIC SIGNALING PATHWAYS IN HEART

The importance of alpha1-adrenergic signal transduction pathways in cardiac muscle is demonstrated by their regulatory effects on cell growth (hypertrophy), contractility, chronotropy and energy metabolism. The aim of this proposal is to determine the proximal steps in the alpha1- adrenergic signal transduction pathways that modulate hypertrophy and chronotropy in cultured, neonatal cardiac myocytes. The advantages in using cultured, cardiac myocytes for these studies include the ability of these cells to be maintained in serum-free medium for several days, and to undergo microinjection or transfection, allowing direct experimental manipulation of specific steps in the signal transduction pathway. Specifically, this proposal will seek: l) to determine the number, type and abundance of alpha1-adrenergic receptor, G protein, and phospholipase C subtypes in cardiac muscle cells; 2) to determine the contribution of the various alpha1-adrenergic receptor subtypes in mediating hypertrophic and chronotropic responses; 3) to determine the role of specific G protein(s) in coupling the distinct alpha1-adrenergic receptor subtypes to the hypertrophic and chronotropic responses; 4) to determine if Ins l,4,5-P3 and diacylglycerol are differential signals for hypertrophy and chronotropy; and 5) to determine the molecular basis for changes in alpha1-adrenergic responsiveness during cardiac development. The experimental approach will be to first identify potential proteins involved in the alpha1-adrenergic signaling transduction pathway, and then to perturb the pathway, by microinjecting or transfecting genes encoding these proteins or the proteins themselves, and determining the effect of this perturbation on alpha1-adrenergic-mediated hypertrophic and chronotropic responses. Hypertrophic growth will be assessed by monitoring the induction of specific marker genes or proteins for atrial naturietic factor and myosin light chain-2. Chronotropy will be determined by monitoring the beat-to-beat Ca2+ transients with the fluorescent indicator dye fura 2. The information expected from the proposed studies will begin to elucidate the molecular basis underlying the diversity of alpha1- adrenergic receptor-mediated effects in cardiac muscle during development.